RESEARCH IN MENTAL RETARDATION AND CHILD DEVELOPMENT

The University of Washington's Mental Retardation and Developmental Disabilities Research Center (MRDDRC), based at the Center on Human Development and Disability (CHDD), provides a comprehensive interdisciplinary research program in the field of mental retardation/developmental disabilities related aspects of human development. The overall goals of the CHDD are to prevent mental retardation and related problems of human development and to improved the quality of life for individuals with developmental disabilities. To help accomplish this, research is carried out in six major areas: 1) Teratology, 2) Developmental and Molecular Genetics, 3) Perinatal Biology, 4) Developmental Neuroscience, 5) Developmental Processes, and 6) Biomedical and Behavioral Outcome and Intervention. Through this grant application, support is requested for scientific core facilities and one administrative core to enhance the effectiveness of the approximately 150 scientists carrying out their activities within the six (MRDDRC) research programs. The scientific core support facilities are as follows: Genetics, Neuroscience, Behavioral Science, Infant Primate Research Laboratory, and Instrument Development Laboratory. Other MRDDRC objectives include training researchers in various disciplines, disseminating research findings, and maintaining linkages to clinical training activities and exemplary service program.